Examining the Gut Microbiome in Haitians Post-Migration to the United States

ABSTRACT. Haitians comprise one of the fastest growing subgroups of immigrants in the US. These
immigrants experience high levels of psychological distress (i.e., depression, anxiety, fatigue, and pain),
contributing to progressive functional impairment, disability, economic burden, and poor long-term health
outcomes. Knowledge of factors contributing to psychological distress early in the post-migration period and
longitudinally will help inform type and timing of interventions to reduce the disabling effects of psychological
distress and improve quality of life for this underserved population. Yet no studies have examined
psychological distress and its underlying biobehavioral, psychosocial, and cultural characteristics in Haitian
immigrants within the first few months of residence in the US or over time. While multiple biological processes
may be associated with psychological distress, rising evidence suggests that gut microbiome (GM) diversity
and composition play an important role via the bidirectional microbiome-gut-brain axis. After migration,
changes in GM composition and diversity embody changes in the social determinants of health ([SDoH]; e.g.,
stress, sociodemographic factors, lifestyle behaviors, dietary patterns, acculturation, environmental and
sociocultural conditions) that also contribute to risk for psychological distress. With more time in the US, the
GM of recent immigrants becomes more Westernized, with reductions of microbial phylogenetic diversity and
native GM species as well as genera-level shifts in microbiota abundance. The SDoH that drive these GM
changes are modifiable through culturally responsive interventions. The GM thus has the potential to serve as
both an early indicator of risk for psychological distress and a tool to mitigate its effects. The overall goal for
this longitudinal pilot cohort study is to investigate associations between psychological distress, GM
composition/diversity, and post-migration SDoH in recent Haitian immigrants to the US. Specific aims are to 1)
Characterize the GM in 60 recent Haitian immigrants by analyzing self-collected stool samples at T1 (< 6
months in the US) and T2 (6 months after T1) and describe changes in composition/diversity over time and 2)
Examine longitudinal associations between post-migration SDoH, GM composition/diversity, and psychological
distress among recent Haitian immigrants. I hypothesize that, in recent Haitian immigrants, a) migration to the
US is associated with changes in GM composition and diversity over time, and b) changes in GM composition
and diversity are associated with changes in post-migration SDoH and psychological distress. The PI has
assembled an interdisciplinary mentoring team of senior scientists with expertise in symptom science, GM,
biocultural approaches, immigrant health disparities, genomics, and bioinformatics. This project will provide the
foundation for the PI to build an independent translational research program focused on developing culturally
responsive targeted interventions that mitigate psychological distress, improve long-term health outcomes,
reduce health disparities, and increase health equity in ethnic-minority immigrant populations.

Public health relevance
PROJECT NARRATIVE Haitian immigrants to the US, who comprise one of the fastest-growing and most-understudied immigrant subgroups in the country, experience high levels of post-migration psychological distress (i.e., depression, anxiety, fatigue, and pain), which contribute to progressive functional impairment, disability, economic burden, and poor long-term health outcomes. Evidence suggests that the gut microbiome (GM; i.e., the collective genomes of microbes living in the gut) plays an important role in the development and persistence of psychological distress and, further, that the GM is modifiable through interventions targeting social determinants of health (SDoH) like stress, lifestyle behaviors, dietary patterns, environmental/sociocultural conditions, and sociodemographic characteristics. The present study will investigate associations between psychological distress, the GM, and post-migration SDoH in recent Haitian immigrants to the US as a critical step in developing culturally responsive, personalized interventions to mitigate psychological distress, improve long-term health outcomes, reduce health disparities, and increase health equity in this underserved population.